Scientific Information Management and Literature-based Evaluations for the NTP - Support for Scientific Meetings

The Division of the National Toxicology Program requires support for a number of scientific meetings was a broad focus on topics to support programmatic activities. These meetings help bring together experts in the field for discussion and review of project and program concepts. DNTP utilizes these meetings as a scientific sounding board and to continuously improve scientific research strategies.